Research Training in Gastrointestinal and Hepatic Diseases

PROJECT SUMMARY
The accelerating pace of discovery in the basic biomedical, clinical and translational sciences now provides
unprecedented opportunities to transform patient care in gastrointestinal and liver diseases. Over the past 35
years, Brigham and Women’s Hospital (BWH) has made major contributions to the training of academic
gastroenterologists and hepatologists seeking cures for digestive diseases. This application from BWH
requests support for the research training of 4 basic and clinical/translational research fellows, with BWH
providing funding for an additional training slot. Outstanding candidates with strong interests and solid
foundations in research will be recruited and trained to apply their knowledge and skills towards addressing
important unmet clinical needs in the prevention, diagnosis, and treatment of patients with gastrointestinal and
hepatic diseases. Trainees will receive program support for 2 years during which they will follow a structured
and rigorous, but individualized training program. This will be a joint effort of 25 eminent and diverse
preceptors from BWH, Boston Children’s Hospital, Dana Farber Cancer Institute, Harvard Medical School, the
Harvard T.H. Chan School of Public Health, Massachusetts Institute of Technology and the Broad Institute.
These preceptors constitute a network of collaborative researchers, who are international leaders in fields
directly relevant to gastroenterology and hepatology. They have been organized into 4 themed, but
interconnected research training units: cell biology, immunology and microbiology; metabolism and
bioengineering; genes, stem cells and development; and clinical and translational sciences. These training
units will provide content-specific educational programming and will increase the efficiency of administration
within the training program. Oversight will be provided by a Research Training Executive Committee including
the Program Director and 2 Associate Program Directors, who will also serve as preceptors. Additional
members will provide guidance on mentoring and on achieving and maintaining diversity within the training
program. An outstanding roster of internal and external advisory board members will evaluate the program and
provide specific recommendations that improve its quality, diversity, efficiency and value added to the research
training of our most promising gastroenterology fellows. This highly personalized training program will include:
1) individual development plans; 2) rigorous research training; 3) hands-on experience in cutting-edge
methodologies, and; 4) an integrated curriculum. Trainees will further benefit from the extensive institutional
resources and rich intellectual environment of the participating institutions. Based upon the sustained levels of
interest in our fellowship program, we anticipate a substantial pool of highly qualified candidates and will
maintain a strong focus on diversity. Through its rigorous, structured and highly personalized curriculum, this
training program affirms its commitment to training future leaders in digestive disease research who are
prepared to translate their findings towards improving patient care.

Public health relevance
PROJECT NARRATIVE This research training program addresses a critical need by preparing young physicians for visionary and committed research careers in basic, as well as translational and clinical sciences that improve digestive health, including health care delivery and equity. This program will provide rigorous and personalized training that enables emerging researchers to accelerate the translation of discoveries into new approaches to the diagnosis and management of gastrointestinal and hepatic diseases.